A Multi-Level Evaluation of California's New Medicaid Coverage for the Diabetes Prevention Program

PROJECT SUMMARY/ABSTRACT
Type 2 diabetes (T2DM) is a leading cause of cardiovascular disease, blindness, lower extremity amputations
and kidney failure in the United States, and disproportionately affects minority and low-income Americans. The
Diabetes Prevention Program (DPP) effectively helps adults with prediabetes delay their progression to T2DM.
However, the CDC-supported national DPP expansion has had low uptake among racial and ethnic minority
and low-income adults, who are disproportionally affected by T2DM. In 2019, California legislators passed
Senate Bill 97, which expanded the DPP to include Medi-Cal (California-specific Medicaid) beneficiaries. The
parent grant (R18DK122372) aims to evaluate the effectiveness of this expansion on diabetes risk markers
(e.g., weight change) by utilizing a large longitudinal cohort of Medi-Cal adults from Kaiser Permanente
Northern California (KPNC) and the University of California, Los Angeles (UCLA), two large health systems
with diverse patient populations. The results of the parent grant's main outcomes however may be modified by
the coronavirus disease 2019 (COVID-19) pandemic. The mandated shelter-in-place orders, economic shut
downs and pandemic-related restrictions have resulted in a decrease in exercise and increased weight gain,
along with a decrease in utilization of preventive health care services. However, it is unclear the extent to
which these changes disproportionally affected Medi-Cal beneficiaries, who have been hard hit by the
pandemic. Leveraging three years of longitudinal data (1/1/19-12/31/21), the primary objective of this diversity
supplement is to assess the extent to which the COVID-19 pandemic exacerbated disparities in T2DM
prevention and outcomes between the Medi-Cal and commercially-insured populations. The career
development plan for this diversity supplement will provide the candidate with high-quality mentorship from
experts in T2DM prevention, health disparities, biostatistics and evaluation of natural experiments. Aligned with
this plan and using the R18 parent grant retrospective cohort, the research goals of the proposed diversity
supplement are to: 1) examine differential rates of T2DM screening among California adults following the
COVID-19 pandemic, by insurance status (Medi-Cal vs. commercial) and demographics; 2) examine
differential changes in T2DM risk factors (exercise and weight) among California adults following the COVID-
19 pandemic, by insurance status (Medi-Cal vs. commercial) and demographics; and 3) accounting for
changes in screening rates, examine differential changes in T2DM incidence rate among California adults
following the COVID-19 pandemic, by insurance status (Medi-Cal vs. commercial) and demographics.
Understanding how Medi-Cal beneficiaries were disproportionally affected is important for allocating limited
resources (including DPP) and targeted interventions. Furthermore, the mentorship, career development and
scientific skills gained during this diversity supplement will advance the candidate towards independence
working at the intersection of T2DM prevention and health disparities, with a focus on minority populations.

Public health relevance
PROJECT NARRATIVE The Diabetes Prevention Program (DPP) delays progression from prediabetes to type 2 diabetes (T2DM), however the CDC-supported national DPP expansion has had low uptake among racial and ethnic minority and low-income adults, who are disproportionally affected by T2DM. The parent grant (R18DK122372) aims to evaluate the effect of the California 2019 DPP expansion to include Medi-Cal (California-specific Medicaid) beneficiaries on diabetes risk markers (e.g. weight change) and DPP uptake. Using quasi-experimental research methods, the proposed study will assess the extent to which disparities in T2DM prevention and outcomes were exacerbated during the coronavirus disease 2019 (COVID-19) pandemic between the Medi- Cal and commercially-insured populations, which is important for allocating limited DPP resources and targeted interventions.